DOPPLER EVALUATION, PORTAL VEIN CALIBRE, FLOW, BILIARY ATRESIA

The objective of this study is to determine if changes in portal vein calibre and portal vein flow characteristics discernible by doppler ultrasound, a noninvasive study, correlate with the clinical course in children with biliary atresia.